RDCRC Administrative Unit

Lysosomal diseases are rare, heterogeneous conditions affecting individuals over a dispersed geographic area. In order to facilitate research serving this unique population the Administrative Unit of the Lysosomal Disease Network will serve several important functions. Composed of five Cores: Administrative, Biostatistical, Neurobehaviroal, Neuroimaging, and Pharmacotherapy; the Units responsibilities are varied. The Administrative Unit will facilitate any communication—including go-to-meeting style web conferences—across the Network. Members will assist all project PIs with regulatory and administrative responsibilities, including acting as liaison between PI and the DMCC. A newsletter will also be developed by members of this unit to highlight research and other accomplishments across Consortia. The Biostatistical Core has helped each PI with a proposed project in the development of the statistical needs for their work. With rare disease populations accurate statistical measurements are crucial and this core has the required expertise. Since almost all lysosomal conditions have component central nervous system disease the neuroimaging and neurobehavior cores provide essential consultation for all projects. In the first five years of this consortium, both cores made seminal discoveries regarding brain structure and function in lysosomal disease. New to the consortium this year is the Pharmacotherapy Core. Experts in the field of therapeutic development will be available to all members of the Network. Currently, all studies with treatment or other therapeutic regimens have consulted with the Core. All members of the Administrative Unit will assist the Training Unit in the implementation of new projects nad the mentoring of trainees.

Public health relevance
The Administrative Unit of the Lysosomal Disease Network will facilitate any and all core functions for all members of the Network. The Unit provides administrative, statistical, therapeutic, behavioral, and neurologic support. All members of the Unit will work with other project team members to successfully implement the goals of their individual projects